Trajectories of non-pharmacologic and opioid health services for pain management in association with military readiness and health status outcomes: SUPIC renewal

PROJECT SUMMARY
Parent Grant Description
This application is to supplement our work funded by the National Center for Complementary and Integrative
Health (5R01 AT008404) that is examining suboptimal and evidence-based pain management in service
members served by the Military Health System (MHS) and veterans served in the Veterans Health
Administration (VHA). This innovative study contains data on over 1.66 million service members in all branches
who have two years of observational data in the MHS between federal fiscal years 2017-2021.
Chronic pain contributes to high rates of disability and healthcare burden in the United States. The Institute of
Medicine estimated the annual cost burden is $635 billion from healthcare costs and lost productivity. The
MHS and the VHA are not immune to the broad challenges of pain management witnessed in the civilian
healthcare system. Service members experience frequent injuries, physical stressors, and comorbid
psychological conditions; all of which jeopardize military readiness and require careful consideration in pain
management approaches. Service members who have functional limitations are medically or administratively
separated from active duty service, leaving them to continue their care in the VHA. Spurred by the significant
personal and economic costs of inadequate pain management and over-reliance on opioids, the US healthcare
system, MHS, and VHA joined together to publish the National Pain Strategy and updated clinical practice
guidelines promote complementary, integrative, and other non-pharmacologic therapies (NPT) for pain
management. The SUPIC project has been investigating changes in the MHS and VHA through observational
studies with this overall goal: to advance knowledge on the military readiness and health status
outcomes associated with different care trajectories that utilize nondrug pain management strategies.
The Specific Aims of the SUPIC parent NCCIH grant are to:
Aim 1: a) Characterize trajectories of nonpharmacological therapies utilization for pain management; b)
examine relationships between NPT utilization (e.g., specific modalities, utilization trajectories) and
multidimensional outcomes (e.g., military readiness, opiate utilization, health status); and c) study both
trajectories and outcomes in discrete high-risk subgroups of patients with discrete comorbid mental health
(posttraumatic stress disorder, depression) and pain conditions (e.g., back pain, other musculoskeletal,
headache).
Aim 2: Identify facility- and provider-level factors (full-time equivalent availability for health occupations,
propensity to refer to NPT or prescribe opioids) that explain variation in NPT use and opioid prescribing
between MHS facilities.
Aim 3: a) Describe the demographic, clinical, and treatment history characteristics of individuals in the existing
SUPIC cohort with chronic pain in the MHS who do and do not transition to VHA care; b) identify associations
between NPT receipt in the MHS and long-term health outcomes in the VHA (main effects); and c) identify
selected moderators and mediators of these associations.
Goals of the Supplement
The SUPIC project was developed to characterize pain management strategies utilized in the MHS and
understand the association of optimal and suboptimal pain management strategies with downstream outcomes
among US service members. However, one challenge to observational studies such as SUPIC is “missing
variable bias” related to important contextual factors not available in these data. Specifically, information on
community features representing social determinants of health (SDOH) such as sociodemographic, housing,
delivery system characteristics, unemployment, and income are lacking. These structural and community
features influence one another, as well as individuals within communities, but are absent in most observational
healthcare studies.
The goal of this supplement is to extend the SUPIC project’s current analysis by augmenting our data with
social indicators of health and make the data ready for future machine-learning (ML) applications by forming
clusters based on SDOH and appending ML-ready indicators to be explored in future applications using ML
approaches. The specific aims of this supplement are to:
Aim 1. Create ML-ready datasets of community-level social determinant of health (SDOH) measures,
suitable for geographically linking with other data resources such as claims data. We will acquire,
subset, and clean the Agency for Healthcare Research and Quality (AHRQ) Social Determinants of Health
Data and enhance its usefulness for ML analyses through two steps. First, using agglomerative hierarchical
clustering we will create summary SDOH taxonomy measures for each of the three levels of available
geography (county, ZIP, census tract). These measures, suitable for attaching to more granular data sources,
will provide low-dimensional summaries of community SDOH characteristics. Second, we will generate power
terms and interactions among the SDOH features up to order of magnitude 3, as well as interactions with the
cluster indicators to facilitate downstream ML analyses.
Aim 2. Analyze, interpret and document the clusters created under Aim 1 to promote transparency and
ensure their utility for downstream researchers. To characterize the composition of the clusters we will
perform descriptive analyses of the features within each cluster and compare these features across clusters. In
addition, we will estimate a multinomial logit model of cluster membership to identify the features that are most
associated with each of the clusters. To enhance the transparency and usefulness of the data, we will create a
handbook documenting the specifics of the cluster analyses, profiling the clusters, naming and interpreting
them, and characterizing their spatial distribution.
Aim 3. Demonstrate the feasibility and value of linking the community-level SDOH database with claims
data by linking the SDOH and SUPIC databases. We will geographically link the SDOH data to SUPIC
claims data and illustrate the application of a ML estimation algorithm that draws on data across ecological
levels. Among military members who are being treated for pain management, we will conduct an exploratory
analysis of the risk of an adverse outcome (defined as primary diagnosis of opioid use disorder, emergency
department diagnosis of self-harm event, or opioid/other drug overdose) using Lasso regression on one-half
the SUPIC data. We will then use causal forests on the reserved half of the data to obtain a causal estimate of
the effect of one of our ML predictors on adverse outcomes. The algorithms used, and results from, this
application to claims data will be described in the ML-ready public use file data documentation.
Aim 4. Deliver the ML-ready database and our extensive documentation to the Inter-university
Consortium for Political and Social Research (ICPSR) data repository for public use. We will prepare
and submit the enhanced SDOH dataset, along with documentation, to the ICPSR data repository. The
database will provide county-, zip code-, and tract-level AHRQ SDOH features, and the cluster indicators from
our analyses. Documentation will characterize the algorithms to create the SDOH clusters and describe and
interpret the cluster indicators. Algorithms for application to claims data will be described. This unrestricted
public data set will be ready to support future machine learning analyses with multiple populations in the US, in
addition to future ML grants with the SUPIC military database.
With a strong, established, and expandable research database of MHS data and an experienced team of
investigators and ML experts, this supplement is poised to transform the SUPIC database into a ML-ready
resource, combined with ML-ready social determinants of health indicators, which can be used to extend much
needed work on pain management that can directly inform MHS leaders and facilitate informed clinical and
organizational changes among other institutions as well.

Public health relevance
Project Narrative This application is to supplement work funded by the National Center for Complementary and Integrative Health (5R01 AT008404) that is examining suboptimal and evidence-based pain management in service members served by the Military Health System (MHS) and veterans served in the Veterans Health Administration (VHA). The goal of this supplement is to extend current analysis by augmenting the project’s data with publicly available social indicators of health (Social Determinants of Health) and make the SDOH data ready for future machine- learning (ML) applications by forming clusters based on SDOH to append to healthcare data sets to be explored in future applications using ML approaches. A handbook with transparent documentation on the data assessment, cluster formation algorithms, and characterization of the clusters will be presented in a handbook for future database users.